Bile Acid on Esophageal Nociceptor

Summary
Esophageal nociceptive sensations, such as heartburn and chest pain, are the major complaints that present in
many esophageal disorders, including GERD. More than 30% of these symptoms are refractory to acid inhibition
by PPIs, making it a significant treatment challenge. Bile acid is a potent substance that can trigger esophageal
nociceptive sensations in addition to acid, but the underlying mechanism of its neuronal action is still unknown.
Our recent study demonstrated that bile acid not only directly activates esophageal nociceptive C-fibers but also
sensitizes their responses to TRPV1 agonist capsaicin. Whether MrgprX4, a newly discovered bile acid receptor,
mediates bile acid-elicited activation and sensitization of esophageal C-fibers and enhances their responses to
acid are important yet unanswered questions. In the present proposal, we address the hypothesis that MrgprX4
contributes to PPI-refractory esophageal nociception by mediating bile acid-induced activation (independent of
acid) and sensitization (increasing acid sensitivity) of esophageal nociceptive C-fibers. Aim 1 will characterize
MrgprX4 expression in esophageal afferent C-fiber neuron subtypes. Using MrgprX4-expressing mice, we will
first clarify MrgprX4 mRNA expression and co-expression with transcripts of nociceptive neurons by single-cell
RT-PCR in esophageal-labeled afferent neurons. We will then characterize MrgprX4 protein expression in
esophageal-labeled afferent neurons regarding neuron diameters and co-expression of C-fiber markers (i.e.
CGRP/IB4). We hypothesize that MrgprX4-positive neurons are small-size unmyelinated C-fiber neurons (but
not NF-200-positive Ad-fiber neurons). Next, we address the hypothesis that MrgprX4 is selectively expressed
in subsets of TRPV1-positive (acid-sensitive) nociceptive C-fiber neurons with their nerve fibers richly distributed
in esophageal mucosa. Aim 2 will determine MrgprX4-mediated activation of esophageal nociceptive C-fiber
subtypes. Our previous study demonstrated that bile acid DCA directly activates esophageal vagal nodose and
jugular C-fibers. Using our newly established MrgprX4-expressing and MrgprX4-/- mouse lines, we will address
the hypothesis that MrgprX4 specific agonists (SML3371 and nateglinide), mimicking bile acid-induced effect,
directly activate esophageal nociceptive C-fiber subtypes. We will then address the hypothesis that bile acid-
induced activation effects on the neuron soma and the nerve terminals of esophageal vagal and DRG C-fiber
subtypes are absent in the MrgprX4-/- mouse line. Aim 3 will determine MrgprX4-mediated sensitization of
esophageal C-fiber subtypes. We will address the hypothesis that MrgprX4 mediates bile acid-induced
enhancement of acid response in esophageal TRPV1-positive C-fibers. Using MrgprX4-expressing mouse line,
we will first determine bile acid-induced sensitization of acid response in esophageal C-fiber subtypes. We will
then determine whether MrgprX4 selective agonists mimic bile acid-induced excessive acid responses in
esophageal C-fiber subtypes. Lastly, we will determine, in MrgprX4-/- mouse line, bile acid and MrgprX4 agonist-
induced effects on acid responses in esophageal C-fiber subtypes.

Public health relevance
Project Narrative MrgprX4 belongs to the recently discovered Mrgpr family that is predominantly expressed in a subset of DRG C- fiber neurons and in the skin and mediates bile acid-induced itch and pain sensations in both rodent and human subjects. The present proposal aims to determine the expression and function of Mrgpr in esophageal nociceptive C-fiber neurons by addressing the hypothesis that Mrgpr contributes to PPI-refractory esophageal nociception by mediating bile acid-induced activation (independent of acid) and sensitization (increasing acid sensitivity) of esophageal acid-sensitive C-fibers. Accomplishing the goal of this project will help to better understand the mechanism underlying esophageal nociceptor activation and sensitization, which may lead to developing a novel treatment approach for PPI refractory esophageal nociception.